Impact of Combined Recovery Program and Home Telehealth Among Veterans with substance use disorders in the VA Inpatient Setting

Justification: High inpatient readmissions among Veterans with SUDs constitutes a costly and persistent
healthcare problem. VHA Handbook 1160.06 guides the development and implementation of recovery-oriented
mental health (MH) services, although significant service gaps remain on VA inpatient settings. ‘Combined
Recovery Program (CRP)’ is designed to address these gaps by enhancing stabilization of Veterans with SUDs
beyond hospital discharge and consists of ‘Group Motivational Interviewing’, an adaptation of motivational
interviewing; and ‘Life Skills for Housing Maintenance’, involving skills training for enhancing housing stability.
To be added to CRP, Stable & Able (S&A) is a VA Home Telehealth (HT) nurse-monitored program providing
assessment and self-management skills in the post-hospitalization phase.
Gaps Addressed: This proposal addresses VA research priorities: access to care and MH, benefitting Veterans
with SUDs. A significant proportion of these Veterans exhibit homelessness and suicidality. Study objectives
address SAIL MH Composite measures ‘PDE1’ to increase Post-Discharge Treatment Engagement in MH care;
and ‘HRF7’ to increase care processes for Veterans at high risk for suicide. During the COVID-19 pandemic,
telehealth solutions offer safe treatment options as well as reduce isolation.
Innovativeness: This proposal is consistent with 2018 MISSION Act in priority areas: mental illness, SUD, and
housing instability via a technology-enabled format and through addressing gaps in the current inpatient recovery
model involving limited availability of staff training in and availability of recovery-oriented services. CRP and S&A
present innovative/novel interventions ready for deployment. Both CRP and S&A were designed specifically to
assist high risk Veterans with SUDs to remain stably housed. S&A is conveniently provided via App using an
iPad, cell phone, or the Medtronic Commander Flex and allows 3 mos. of daily monitoring by trained HT staff.
Specific Aim I: Assess the relative effects of Treatment Engagement and Substance Use [and SUD-related
problems] between CRP+S&A vs. CRP and CRP+S&A vs. TAU by 3-mos follow-up.
Primary Hypothesis 1a: Treatment Engagement: Participants in CRP + S&A will attend more outpatient SUD
treatment sessions and general MH treatment sessions compared to participants in CRP and to TAU.
Primary Hypothesis 1b: Substance Use: Participants in CRP + S&A will lower quantity and frequency of
substance use and SUD-related problems compared to participants in CRP and to TAU.
Secondary Hypothesis 1c: Preventable Services: Participants in CRP + S&A will reduce Preventable
Healthcare Services (hospital readmissions and ED visits) compared to participants in CRP and to TAU.
Secondary Hypothesis 1d: Participants in CRP + S&A will report Greater QoL; # of Days Living in Stable
Housing; and # of Days Engaging in Community Events and/or Activities compared to CRP and to TAU.
Specific Aim II: Conduct Veteran participant thematic interviews and Staff ‘focus’ interviews to assess qualitative
facilitators and barriers to implementation.
Project Methods: 195 Veterans with SUDs in the Charleston VAMC inpatient setting will be recruited.
Participants will be randomly assigned to: (1) CRP + S&A; (2) CRP; and (3) TAU. Participants will be followed-
up at 1 and 3-months and data analyzed using mixed methods. Investigators of this project plan to evaluate
implementation of the interventions proposed in other VA inpatient programs within the VISN through future
implementation projects and will utilize study findings in partnership for improving SAIL performance measures.
Description of Primary Outcomes: A. Treatment Engagement (measured in SUD and general MH treatment
sessions attended); B. Substance Use (measured in quantity and frequency) and SUD-related problems.
Secondary outcomes: C. Preventable Services (measured in hospital readmissions and ED visits) and D. Quality
of Life, #Days Living in Stable Housing, and # Days Engaging in Community Events and/or Activities.

Public health relevance
A significant proportion of Veterans with substance use disorders (SUDs) have co-occurring psychiatric disorders, the combination of which frequently leads to high inpatient service utilization. Homelessness and higher risk for suicide is common among this population. The combination of SUD with co-morbid MH diagnoses warrants innovative treatment approaches that: a) identify and treat patients during their most vulnerable periods; b) leverage technology; c) partner with current VA programs (e.g. Home Telehealth) and operational priorities (i.e., VHA Handbook 1160.06), toward the goal of reducing inpatient admissions, enhancing treatment engagement and reducing SUD. This study investigates the effectiveness of Combined Recovery Program (CRP) for Veterans with SUDs in the inpatient setting and Home Telehealth in the aftercare setting. Outcomes are assessed at 1 and 3-month follow-up using a multi-modal approach. The ultimate goal is to increase outpatient utilization, reduce substance use, and reduce inpatient/ED visits.